ACTG 377:PRAM2: PH I &II RM,MC,COMPARING 4 ANTIRETROVIRAL AGENTS PRO

This study will compare 4 different study drug combinations for treatment of HIV infection. The purpose of this study is to see which of these study drug combinations does the best job of reducing HIV in the blood. Safety and tolerability of these drugs in children will be assessed.